Gastrointestinal cell type-specific signaling and C. difficile toxin pathogenesis

Nationwide, Clostridioides (formerly Clostridium) difficile infection is the most common cause of antibiotic-
associated diarrhea and the most frequent hospital-acquired infection. Recent epidemiological studies have
shown an alarming increase in incidence of C. difficile infection in disabled Veterans. Hospital-based infection
control programs and careful choice of antibiotic treatments have been beneficial, but recurrent and drug-
resistant C. difficile infections persistently burden the VA healthcare system. Therapeutically, fecal microbiota
transplant has shown promising success but lacks specificity and standardization. To identify new therapeutic
targets or strategies for disease prevention, a better fundamental understanding of how C. difficile toxins damage
colonic tissue, and how the human host responds, is essential.
Pathogenic strains of C. difficile produce toxin A (TcdA) and/or toxin B (TcdB), which directly kill host cells
and induce an inflammatory response in the colonic mucosa. Clinical isolates of C. difficile encoding TcdB alone
are sufficient to produce the whole spectrum of pathology in patients with C. difficile infection. Bezlotoxumab is
a neutralizing antibody against TcdB and a therapeutic drug for preventing recurrent C. difficile infection.
Therefore, TcdB is considered a prominent driver of human disease and will be the specific focus of this proposal.
Recently, significant progress has been made to identify host cell surface receptors for TcdB, specifically Nectin-
3, CSPG4, and the Frizzled family of Wnt receptor proteins. The expression of these receptors in human colonic
tissue and their respective contribution to TcdB function is not clearly understood. Furthermore, the epithelial cell
subtypes targeted by TcdB and how interactions with these cells contribute to pathogenesis during the course
of C. difficile infection is understudied. Emerging data suggest TcdB specifically targets the stem and progenitor
cells in the base of colonic crypts potentially with the effect of delaying epithelial reconstitution. The Frizzled
family of receptors are critical for regulating colonic stem cell function. Additionally, TcdB transactivates the
epidermal growth factor receptor (EGFR), a mediator of colonic epithelial cell stem cell behavior. This proposal
is based on preliminary data suggesting EGFR, ErbB2, and ErbB3 receptors facilitate TcdB-induced cell death.
The effect of TcdB on ErbB signaling has not been studied in vivo, and the impact of this pathway on C. difficile
pathogenesis is not known.
Given the relevance of ErbB signaling to colonic stem cell behavior in homeostasis and injury repair, it may
be that targeting stem or progenitor cells is a critical mechanism of TcdB virulence. The main hypothesis of
this proposal is TcdB induces ErbB signaling in colonic stem/progenitor cells as an important
component of the pathogenesis of C. difficile infection. The proposed experiments are aimed at using
recombinant TcdB and isogenic C. difficile spores with in vivo mouse models and ex vivo human colonoids to
understand how TcdB interacts with ErbB receptors in gastrointestinal epithelial cells. The results will determine:
(1) the ability of wild type and specific mutant TcdB toxins deficient in receptor binding to alter ErbB pathways in
vivo; (2) the impact and mechanism of ErbB inhibition on TcdB-mediated cell death; (3) the specific cell subtypes
that are affected during TcdB-mediated colonic injury. The long-term goal of this work is to reveal targets for
therapeutic strategies that interdict the pathogenesis of C. difficile infection.

Public health relevance
C. difficile infection is the most common hospital-acquired infection in the United States. Recent epidemiological data show an increasing incidence of C. difficile infection in Veterans, particularly non-hospital, community- acquired disease. This alarming trend illustrates the need for more knowledge about this potentially deadly bacterial infection. A better fundamental understanding of how C. difficile toxins target the human colon, and how the human cells and molecules respond to damage, is required for identifying new therapeutic and preventive opportunities. This proposal addresses this need by defining the molecular actions responsible for C. difficile infection. This innovative proposal will advance the science of gastrointestinal microbiology, and ultimately, the results are expected to reveal novel targets for treatments to ease the suffering of our nation’s Veterans.